Vibrio cholerae quorum sensing as an intestinal symbiosis factor in a model arthropod host

Abstract/Project Summary
Vibrio cholerae is a human diarrheal pathogen and an environmental organism that persists in the arthropod
intestine. Our preliminary results suggest that the V. cholerae high cell density quorum sensing regulator
HapR orchestrates the metabolic transition of this microbe from intestinal pathogen to intestinal symbiont by
extending host life span, activating host innate immunity and epithelial repair mechanisms, and promoting host
metabolic homeostasis. Here we use the powerful genetics of the model arthropod Drosophila melanogaster
to understand the lines of communication between host and pathogen that underlie this transition.
We will identify bacterial metabolites that activate host innate immunity and trace the host pathways that are
co-opted by the bacterium for this purpose. We will determine whether the arthropod intestinal mucus or
peritrophic membrane supports growth of V. cholerae and whether digestion by HapR-activated degradative
enzymes activates peritrophic membrane synthesis. Finally, we will explore the role of V. cholerae-derived
tryptophan in promoting host metabolic homeostasis. These studies not only expand our appreciation of the
role of V. cholerae HapR in the host-pathogen interaction but also provide a new paradigm of quorum sensing
control of the host-microbe symbiosis.

Public health relevance
Project Narrative Our laboratory has recently discovered that high cell density quorum sensing signaling promotes a symbiosis between V. cholerae and the model arthropod host Drosophila melanogaster. In particular, the high cell density master regulator HapR activates interactions of V. cholerae with the host intestine that are normally attributed to intestinal symbionts including increased host innate immune signaling, digestion of the mucus-like peritrophic matrix synthesis, and host tryptophan metabolism. Here we seek to elucidate the host and pathogen regulatory pathways that engender this response. These findings will expand our appreciation of the role of quorum sensing in the persistence of the human pathogen V. cholerae and will establish new paradigms for metabolic communication between intestinal pathogens and their hosts.